MIGHTIER: Movement in Heart Transplant patients: the Impact of Environmental factoRs

PROJECT SUMMARY/ABSTRACT
Long term survival of pediatric heart transplant (HT) patients remains unacceptably low and is driven in part by
modifiable cardiovascular risk factors. Children with HT engage in low levels of moderate to vigorous physical
activity (MVPA), which is a major health problem for a population already at increased cardiovascular risk and
further contributes to their morbidity and mortality. Increasing MVPA may be a critical way to improve
cardiovascular health, quality of life, and survival in this population. While environmental exposures are
associated with physical activity in children without HT, their effects in those with HT are unknown, and likely
different. To design effective, equitable, generalizable, and sustainable interventions to increase MVPA, we
need to recognize the environmental determinants of MVPA and involve stakeholders in intervention
development. Jonathan Edelson, MD, is a pediatric cardiologist and physician-scientist passionate about
understanding how physical activity can improve outcomes of children after HT. With a mentoring team
specializing in implementation science, Dr. Edelson will 1) develop expertise in mobile health technology and
accelerometry; 2) hone the skills to design, launch, oversee, and complete a multisite, prospective
interventional study; and 3) gain methodologic expertise in geospatial and qualitative methodology. This study
proposes to leverage Dr. Edelson's existing mobile health studies of pediatric HT patients to evaluate the
macro and micro environmental determinants of MVPA in pediatric HT and to pilot an exercise intervention
using the Multiphase Optimization Strategy (MOST). Specific Aims are to 1) Determine the association of the
macro-environment with MVPA in a socioeconomically diverse cohort of children after HT; 2) Use qualitative
methodology to identify micro-environmental determinants of participation in physical activity in pediatric HT
patients; 3) Determine the feasibility and preliminary efficacy of a digital exercise program in pediatric HT
patients. Dr. Edelson will map participant addresses to neighborhood-level built and natural environmental
exposures to estimate the association of MVPA patterns with macro environmental factors. He will then
conduct semi-structured interviews informed by the COM-B (Capability, Opportunity, Motivation, Behavior)
implementation science framework with patients and their families to identify determinants of physical activity
and desirable components of a mobile health exercise intervention. Finally, he will apply the knowledge gained
to the development and implementation of a prospective pilot longitudinal exercise intervention using MOST, a
strategy for developing multi-component intervention which has successfully informed physical activity
interventions. This K23 award will support Dr. Edelson's pathway to becoming an independent investigator in
the interventional space with skills that will support future R level proposals using exercise in a large multisite
cohort to improve long-term outcomes. This work will provide a novel framework for exercise interventions that
will be applicable to a range of populations, further highlighting the public health significance of this proposal.

Public health relevance
PROJECT NARRATIVE The long-term survival of pediatric heart transplant (HT) patients remains unacceptably low and is limited in part by modifiable cardiovascular risk factors. Increasing moderate to vigorous physical activity (MVPA) improves cardiovascular health in these children, but efforts to do so effectively and equitably are hindered by the lack of an understanding of the environmental associations with MVPA. This proposal seeks to use quantitative and qualitative methods to assess the macro and micro environmental determinants of MVPA in pediatric HT and to design and evaluate a pilot study of a longitudinal multi-component exercise intervention.